Community I-STAR Mozambique: Community Implementation of SBIRT using Technology for Alcohol use Reduction in Mozambique

Hazardous drinking (HD) is a major public health burden worldwide with significant morbidity and mortality.
To reduce HD, the WHO recommends using Screening, Brief Intervention, Referral to Treatment (SBIRT). Mobile
health technology (mHealth), such as the mSBIRT app developed by members of our team, is a promising tool
for widespread cost-effective delivery of evidence-based HDS by community health workers (CHWs) because
of its potential to increase fidelity, effectiveness, and sustainability. Community I-STAR (Implementation of
SBIRT using Technology for Alcohol use Reduction) Mozambique comprises three phases: 1) mSBIRT
adaptation – completed, 2) a cluster-randomized trial – in progress, and 3) scale-up of the most cost-effective
intervention – to be started after the trial is completed. Community I-STAR Mozambique will scale-up a cost-
effective, sustainable program and inform policy applicable to Mozambique and other LMICs.
Early in the COVID-19 pandemic, all activities were put on hold. Once we were able to restart activities,
the social restrictions during the pandemic required changing how trainings needed to be conducted to ensure
safety. Instead of conducting fewer number of trainings with large numbers of trainees in one site as originally
planned, we had to conduct much more many trainings with smaller number of trainees. Trainers also had to
travel more times from Nampula City or Maputo City to train the (same) number of trainees in rural areas required
to conduct the project as originally proposed. Also, in November 2019, the Ministry of Health (MoH) hired 162
more CHWs to work within the districts where we are conducting the study. Therefore an additional 228 CHWs
need to be trained, which also required hiring more research assistants to provide the support needed at the
clinic (and CHW) level. Also, per diem costs during training of MoH personnel (e.g., CHWs) triplicated as of
11/2019. Therefore, the training budget was much higher than originally planned and training activities have
taken longer than expected, and the changes instituted by the MoH also had a financial impact in our study. This
administrative supplement requests funding to cover the costs of the training the yet to be trained 228 CHWs
that are required to attain the sample needed to test the hypothesis. This administrative supplement application
does not propose changes to the overall human subjects/clinical trial designation of the award and preserves
the parent award’s overall impact within the original scope of the award and the likelihood that this project will
exert a sustained, powerful influence on the field. The administrative supplement will be used only to cover the
cost increases for unanticipated expenses due to COVID-19 or related mitigation efforts that could not be covered
by re-budgeting existing funds without modifications to the original scope of the approved project and is not
intended to support COVID-related research. Because we are about to begin the last year of the award, without
the funds requested in this supplement, the entire investment is at risk. Our request represents a significant need
for additional funds to cover the research activities of this investment.

Public health relevance
Hazardous drinking is a major public health burden worldwide with significant morbidity and mortality. We will examine the implementation and effectiveness of two different strategies to train and supervise community health workers in Mozambique to sustainably provide community-based services to reduce hazardous drinking using the efficacious Screening, Brief Intervention, Referral to Treatment (SBIRT): one strategy using mobile health technology and the other using traditional training and supervision. Our study will leverage existing platforms and participation of policy makers ready to apply and sustain evidence-informed policies over time and it will inform policy decision-making and clinical practice not only in Mozambique but also in many other low- and middle-income countries.